Integration of circulating tumor cell and nuclear imaging biomarkers to assess LuPSMA response and resistance in advanced prostate cancer patients

Project summary/abstract
Prostate cancer accounts for 15% of malignancies and is the second leading cause of cancer-related death in
men. The incidence of prostate cancer worldwide is expected to rise from 1.4 million annually in 2020 to 2.9
million by 2040. While outcomes for cancer localized to the prostate are generally good, they worsen for
metastases (5-year survival: ~30%). Chemo-, hormonal, and immunotherapy options are limited for advanced
prostate cancer and cause significant toxicity. Radiopharmaceutical therapy (RPT) is a new, promising
systemic treatment that preferentially delivers ionizing radiation to tumors expressing certain molecular targets.
Several RPTs targeting the prostate-specific membrane antigen (PSMA) are currently in clinical and research
use. PSMA-RPT is effective for some patients, but identifying patients who will respond to PSMA-RPT and
understanding why patients develop treatment resistance during PSMA-RPT remains challenging. Thus, there
is an unmet clinical need for biomarkers to identify patients with advanced prostate cancer responsive to
PSMA-RPT and robustly monitor treatment resistance during RPT-based therapy.
PSMA-based molecular imaging shows potential for stratifying patient responders and non-responders for
PSMA-RPT but remains imperfect. We and others have shown the potential of liquid biopsy approaches for
treatment monitoring in prostate cancer patients, including different types of RPT. In particular, our group has
developed a novel circulating tumor cell (CTC) biomarker strategy that allows not only the isolation of rare
populations of CTCs in typically acquired clinical blood samples but also maintains their integrity to probe the
transcriptomic profile of the CTCs. In preliminary testing, we have found that this novel CTC technology
complements PSMA-based molecular imaging for monitoring patients being treated with the RPT agent 177Lu-
PSMA-617 (LuPSMA). We have additionally developed novel machine learning approaches to refine and
optimize the integration of these biomarkers. Therefore, in response to FOA PAR-21-290, we propose to
systematically optimize and understand the integration of CTC and nuclear medicine imaging for LuPSMA
assessment. Our overarching hypothesis is that fluid-based CTC and non-invasive imaging biomarkers are
complementary and synergistic for assessing patient response to LuPSMA. We will achieve this goal through 2
specific Aims. Aim 1: Correlate pre-treatment CTC profiles with changes in PSMA-avid tumor burden during
LuPSMA therapy. Aim 2: Correlate CTC and imaging biomarker dynamics during LuPSMA treatment with
progression-free survival. If successful, the outcomes of this work will provide the impetus for widespread
assessment of these integrated biomarkers in clinical trials and drive focused preclinical studies to understand
RPT biology further.

Public health relevance
Project narrative Biomarkers are needed to identify patients with advanced prostate cancer who respond or not respond to the newly FDA-approved radiopharmaceutical therapy LuPSMA. Clinical molecular imaging using PSMA-targeted agents shows potential as an imaging biomarker for this purpose but remains imperfect. This proposal will explore the combination of these imaging biomarkers with our novel circulating tumor cell liquid biopsy assay as a better-integrated biomarker for patients on LuPSMA.